The University of Michigan Education and Research Center

Research & Related Other Project Information
Overall
Overall. 7 Project Summary/Abstract
Since inception in 1982, the University of Michigan ERC, the Center for Occupational Health and Safety
Engineering, has provided comprehensive graduate-level educational programs to aspiring practitioners and
researchers in Industrial Hygiene (IH), Occupational Health Nursing (OHN), Occupational Safety Engineering
(OSE), and Occupational & Environmental Epidemiology (OEE). Our academic programs are complemented
with our highly effective Pilot Project Research Training (PPRT), Outreach, Continuing Education (CE), and
Targeted Research Training Programs (TRT). Our academic and research programs provide interdisciplinary
academic training to ensure that graduates are qualified to pursue careers and assume leadership roles in the
practice of occupational health and safety (OHS), and to help ensure an adequate supply of well-trained
professionals to help meet the nation's needs. Our success as a center of excellence is predicated on (1) an
outstanding, dedicated and stable faculty; (2) interdisciplinary curricula that prepare our graduates for modern
practice; (3) vibrant extramurally funded research programs and stellar research productivity in NORA-related
areas that train next-generation research leaders; (4) multifaceted and innovative Outreach and CE programs
that meet the needs of professionals in our region and beyond; (5) strong institutional support; and (6) active
and engaged alumni, many of whom are leaders in their fields. Highlights of the past 4-year period (2018-
2022) include: new faculty hires and promotions in all programs; numerous scholarly publications by faculty
and students; new courses and the development of new specializations; and increased regional collaborations.
During this period, 180 NIOSH supported graduate students were enrolled (134 Master’s and 46 doctoral), and
71 Master's and 23 doctoral degrees were awarded. Our CE program in the past 4-year period conducted 140
CE programs, attended by 16,773 people, resulting in nearly 104,591 contact hours of training across many
OHS areas. Goals for the next 5 years include: (1) continuing to enhance our curricula to meet evolving
training needs; (2) increasing awareness of OHS and enrollment in our programs; (3) initiating new program
specialties to expand our impact; (4) continuing to offer high quality CE courses; (5) maintaining research
programs at the cutting edge of the occupational health sciences and using research-to-practice mechanisms
and partnerships to move research results into the workplace; and (6) increasing alumni engagement.

Public health relevance
Research & Related Other Project Information Overall Overall. 8 Project Narrative The US workforce continues to carry a disproportionate burden of preventable job-related morbidity and mortality, resulting in part from national and regional trends that tend to adversely affect the health, safety and welfare of workers. By training high-quality practitioners and researchers, the Michigan ERC helps to meet critical shortfalls in health and safety services in most small and many larger workplaces, and thereby reduces the incidence and severity of occupational injury and illness.